Feasibility of app-delivered circadian synchronization therapy with light in a cohort of pregnant women

PROJECT SUMMARY
Circadian rhythms play a vital role in promoting maternal health and managing pregnancy outcomes, including
gestational diabetes, preterm birth, and postpartum depression. However, interventions to mitigate circadian
rhythms disruption during pregnancy are lacking, despite readily available non-pharmacological circadian
interventions. The circadian timekeeping system is strengthened and aligned to the 24-hour day by light, and
environmental light manipulations can shift the phase and alter the amplitude of circadian rhythms when based
on careful timing and combined with other behaviors.
This Phase I STTR project aims to evaluate the feasibility of circadian synchronization therapy with light
(CST-L) in a socioeconomically diverse population of pregnant women. The intervention involves bright light
exposure at specific times to phase advance, delay, or boost the amplitude of the circadian clock, dim light at
other times, as well as the use of a diary to track the causes of circadian disruption. To evaluate the success of
the trial, we will collect subjective feedback from 20 pregnant women using the app and blue-blocking glasses
for four weeks, and will make iterative updates to the app in response to user feedback. The ultimate goal is to
develop a mobile application for both iOS and Android that delivers CST-L and helps improve maternal mood
and health, as well as infant sleep training. If successful, this intervention could help reduce the risk of preterm
birth, postpartum depression, and other poor outcomes during and after pregnancy.

Public health relevance
NARRATIVE This project aims to develop a mobile app that uses bright light exposure to align the circadian rhythms of pregnant women, which can help prevent negative pregnancy outcomes such as preterm birth and postpartum depression. The app will track circadian disruption and provide personalized interventions to adjust the circadian clock using bright or dim light exposure. The success of the trial will be evaluated through feedback from 20 pregnant women, and if successful, the app could improve maternal health and infant sleep training.